Mechanisms of swallowing dysfunction in a translational rodent model of chronic cervical spinal cord injury

ABSTRACT
Swallowing is a complex motor behavior that relies on rapid, precise coordination between the respiratory and
swallowing pathways to protect the airway. Even minor disruptions in this coordination can result in dysphagia,
which significantly increases the risk of aspiration pneumonia—a leading cause of death among individuals with
neurological disorders. Dysphagia is especially concerning in those with spinal cord injury (SCI), where
pneumonia is responsible for 65% of deaths in individuals with high cervical injuries (C1-C4). While dysphagia
is often considered a transient issue following acute SCI, emerging evidence from both animal and human
studies suggests it may persist into the chronic phase, potentially contributing to silent aspiration and elevated
morbidity.
The fundamental goal of this project is to redefine our understanding of dysphagia following SCI by
investigating the progression and underlying mechanisms of upper airway dysfunction in SCI.
Specifically, we aim to characterize the development and extent of upper airway dysfunction from acute to
chronic phases of cervical SCI using a clinically relevant rodent model of SCI (C4 contusion). Through this model,
we will evaluate how changes in the neurochemical profile of upper airway motor neurons may underpin the
persistence of dysfunction over time. Additionally, we will explore the mechanisms by which chronic SCI
contributes to functional swallowing impairments and aspiration, which seem to differ from those observed in the
acute injury phase.
Utilizing a well-established C4 contusion model of SCI, we will assess time-dependent changes in swallow
function and neural circuit reorganization. This research will lay essential groundwork for future studies aimed
at identifying therapeutic targets to mitigate dysphagia and improve respiratory outcomes for individuals with
chronic SCI. Moreover, our findings may have broader implications for other neurological conditions with high
dysphagia and aspiration rates, including traumatic brain injury and stroke.

Public health relevance
PROJECT NARRATIVE The concept of Impaired swallow function (e.g., dysphagia) after spinal cord injury (SCI) is controversial. Early after SCI, dysphagia and subsequent aspiration are common secondary complications. However, the prevailing view is that these deficits are transient and related to factors independent of SCI. Our goal is to develop a clinically-relevant animal model of swallow dysfunction that characterizes the extent and progression of dysphagia from acute to chronic SCI. These data will enable the development of physiologically-based therapeutic strategies to mitigate or even prevent dysphagia after SCI.